RAMAN CHARACTERIZATION OF MANGANESE OXO COMPLEXES

The manganese aggregate in photosystem II (PSII) is arguably one of the most important metal sites in biology, as it is the source of the O2 required for aerobic life. A number of polynuclear manganese complexes have been prepared which exhibit structural and spectroscopic features relevant to PSII. Raman spectroscopy is being used to study the core structure (Mn4O6)4+ of these complexes to determine the presence of an O-O bond. Formation of an O-O bond between terminal or bridging oxo-ligands prior to release of O2 has been proposed as one of the mechanisms for water oxidation in PSII.